Core C: Biostatistics & Bioinformatics Core

PROJECT SUMMARY/ABSTRACT
The role of the Biostatistics and Bioinformatics Core is to support investigators of the SPORE in Prostate
Cancer at Memorial Sloan Kettering Cancer Center in their research efforts, including laboratory experiments,
the design and analysis of clinical trials, and bioinformatics analyses. For preclinical studies, core members will
assist in the formulation of the experimental design and in the analysis and interpretation of the data at the
conclusion of the studies. A core member will conduct a protocol review with SPORE investigators during the
clinical trial design phase. Based on this review, we will provide a statistical section for the protocol, outlining
major scientific objectives, population to be studied, primary and secondary endpoints, experimental design, a
randomization procedure if necessary, analysis plans, and a targeted sample size justified in probabilistic
terms. At the conclusion of the trial, data analyses will be performed to assess outcomes of the primary and
secondary endpoints stated in the protocol. A similar strategy will be employed for genomic analyses and core
members will be integrated to the individual studies early on, remain involved, and carry full responsibility for all
quantitative aspects.

Public health relevance
PROJECT NARRATIVE The Biostatistics and Bioinformatics Core assists the research efforts of the Memorial Sloan Kettering Cancer Center SPORE in Prostate Cancer investigators, contributing to the design and analysis of clinical, genomic and laboratory research, and the development of valid conclusions. The core provides statistical analysis and consultancy as well as ongoing quality assurance. The core has also established a data quality working group to improve the quality of SPORE data.